Harmonization and Joint Analysis of Human Brain Single-Cell Datasets

Project Summary/Abstract
Neurodegenerative diseases like Alzheimer's, Parkinson's, and Multiple Sclerosis affect millions of people
globally. Researchers have made recent advances in studying these diseases by analyzing single cells in
postmortem brain tissues. But these diseases are complex and hard to understand. We aim to create a
comprehensive atlas of cell types and states in the human brain across the spectrum of neurodegenerative
diseases. We plan to do this by harmonizing and analyzing data with BRAIN Initiative-generated reference data
using state-of-the-art methods. By creating this atlas, we hope to identify potential targets for therapy and develop
new treatments for these debilitating diseases. This project will provide a valuable resource for the neuroscience
community by allowing a more comprehensive understanding of the cellular landscape in healthy and diseased
brains, facilitating comparisons between normal and pathological conditions.

Public health relevance
Project Narrative This project aims to harmonize single-cell transcriptomics datasets from various neurodegenerative diseases with BRAIN Initiative-generated reference data to create a comprehensive atlas of cell types and states in the human brain across the neurodegenerative disease spectrum, offering valuable insights into shared and distinct molecular mechanisms underlying these disorders.